FOXO3 dependent proinflammatory transcription program of AD

PROJECT SUMMARY
The overall goal of the current project is to determine the functional significance of microglial FOXO3 in
Alzheimer’s disease (AD). AD is the leading cause of dementia in the elderly. In addition to the hallmark
pathological features, such as β-amyloid peptide (Aβ) plaques, tangles and widespread neuronal loss, there
are profound inflammatory changes in the AD brain. Microglia, the brain's immune cell, links closely to all
pathological cascades including amyloid, tau and neuroinflammatory changes. Genome-wide association
studies (GWAS) have revealed that the known AD risk genes are predominantly expressed in microglia,
including the genes encoding the triggering receptor expressed on myeloid cells-2 (TREM2). Aberrant
elevation of type-I interferon (IFN-I) signaling, typically associated with an antiviral immune response, has been
observed in AD. Recent studies have identified a microglial IFN-I signature in the aging brain as well as in AD,
suggesting a role for IFN-I signaling in AD pathobiology. We recently demonstrated that the FOXO3 gene,
encoding the transcription factor forkhead box O-3, is a key mediator of cellular stress-induced IFN-I response.
FOXO3 is one of the strongest genetic modifiers that determines the longevity of humans as well as a critical
regulator of aging process. It is highly expressed in the brain with its abundance in microglia. Our preliminary
data shows that FOXO3 signaling is critical for the regulation of lipid droplet accumulation as well as IFN-I
pathway activation in microglial cells. Furthermore, FOXO3 directly mediates the signal from TREM2, a prime
regulator of microglial activities, making it an attractive molecular target for therapeutic intervention in AD.
Despite its critical role in IFN-I response and aging, the role of microglial FOXO3 in AD pathobiology remains
elusive. Our central hypothesis is that aberrantly activated FOXO3 critically contributed to microglial activation
states, including disease-associated microglia (DAM). To this end, our Specific Aims are: To determine the role
for microglial FOXO3 in AD-associated phenotypes in a transgenic mouse model of AD; To investigate the role
for FOXO3 in microglial functions in human iPSC-derived microglia (iMGL) model. The proposed study will
demonstrate the role of microglial FOXO3 in AD pathogenesis and lay the foundation for therapeutic strategies
to restore normal microglia function.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is the leading cause of dementia in the elderly. This project is directly relevant to AD since the proposed study will investigate the role of microglial FOXO3 in AD pathogenesis. The outcome of this study will lay new foundation for therapeutic strategies to restore normal microglia function.